Neurophysiological biomarkers in preclinical assays of risk propensity

PROJECT SUMMARY: Individual humans and animals can lie anywhere along a continuum of high to low risk-
taking propensity. Several neuropsychiatric conditions are characterized by extremes of risk-taking propensity.
For example, patients with pathological anxiety or anorexia nervosa show high risk aversion, while patients
with gambling disorder, or substance use disorder exhibit low risk aversion. Both high and low risk-taking
propensity are thought to drive and maintain maladaptive behavior in these disorders. Therefore, novel
pharmacological agents that shift risk-taking propensity closer to population mean values could provide novel
treatments for these disorders. Although risky decision-making paradigms exist for humans and animals,
behavioral assays that also elicit robust and translationally relevant neurophysiological markers are lacking.
Here, we propose to optimize, pharmacologically test, and mechanistically probe a novel in vivo behavioral and
neurophysiological assay to be used for translational studies and for screening for novel drugs to treat
psychiatric conditions associated with high or low aversion to risk. Recent work in wild-type rats suggests that
the activity of dopamine receptor 2 expressing medium spiny neurons (D2-MSNs) in the nucleus accumbens
core (NAcC) encodes prior outcomes and predicts future choices during a risky decision-making operant task.
First, we will manipulate operant task parameters to establish that the task fully captures both extremes of risk-
taking propensity, and also measures constructs underlying risky decision-making, including reward and loss
sensitivity, motivation, and goal-directed versus habitual responding. We will also identify neurophysiological
markers of risky versus safe choices during the task using fiber photometry and whole brain local field
potentials (LFP). We predict that during the decision period immediately preceding safe or risky lever selection,
increases in both NAcC D2-MSN activity and theta oscillations within a corticostriatal circuit including the
NAcC/ventral striatum (VS), medial prefrontal cortex (mPFC), and orbitofrontal cortex (OFC), will precede safe
choices. In contrast, we predict that decreases in NAcC D2-MSN activity and theta activity within this
corticostriatal circuit will precede risky choices. Theta activity within corticostriatal brain regions will provide a
non-invasive and translationally relevant neurophysiological marker of risk-propensity, while NAcC D2-MSN
activity will provide a marker of risk-propensity for drug screening using animals. Second, we will test whether
drugs with known effects on risky decision-making in humans produce the same effects on the behavior of rats
in the optimized paradigm. We will assess the effects of the dopamine D2/D3 agonist pramipexole, which
increases problem gambling in Parkinson’s Disease, and the D2/D3 antagonist sulpiride, which increases risk
aversion in humans. We will also determine drug effects on NAcC D2-MSN activity and corticostriatal theta.
Third, we will use intra-NAcC drug infusions and optogenetics to test whether changes in NAcC D2-MSN
activity during the decision period of the operant task plays a causal role in safe versus risky decision-making.

Public health relevance
PROJECT NARRATIVE Individual humans and animals can lie anywhere along a continuum of high to low risk-taking propensity. Both extremes of risk-taking propensity are thought to contribute to problematic behavior in several neuropsychiatric conditions, such as pathological anxiety and anorexia nervosa (low risk-taking propensity), and gambling disorder and substance abuse disorder (high risk-taking propensity). This project will develop, optimize, and mechanistically test a novel risky decision-making assay for use in screening for novel therapeutics, and eventual translation to humans.